Structural-functional studies of gingipain biogenesis and localization

PROJECT SUMMARY
There is an urgent need to explore new therapeutic approaches in the management of
periodontitis, a prevalent and chronic disease that currently lacks effective treatment. Further, a
growing number of studies have linked periodontitis to systemic diseases such as atherosclerosis
or rheumatoid arthritis, as well as some cancers, diabetes, and Alzheimer’s disease.
Porphyromonas gingivalis, a black-pigmented, Gram-negative anaerobe, is a keystone pathogen
in microbial-induced periodontal disease. A comprehensive mechanistic understanding of some
of its virulence factors is essential as the first step for therapeutic development. The bacterium
uses a Type IV Secretion System to secrete an array of virulence factors, including gingipains
[cysteine proteases – Arg-specific RgpA and RgpB, and Lys-specific Kgp], which are essential for
its pathogenicity. There is still a significant gap in our understanding of the mechanism of post-
translational proteolytic processing of progingipains and membrane surface assembly of non-
covalent complexes composed of a catalytic domain and hemagglutinin (HA) domains. In addition,
the role of HA domains in P. gingivalis pathogenesis is unclear. Our objective is to expand the
understanding of the gingipains' hemagglutinating/adhesive properties and the formation of their
surface complexes. The specific aims of the current application are designed for a comprehensive
assessment of the gingipain structure-function properties, including its biogenesis and specific
localization. Experiments are outlined to determine the post-translational sequential processing
steps leading to the formation of gingipain complexes on the bacterial surface. We will conduct a
comparative analysis of proteolytic activity independent biological functions of single-chain pro
gingipains and assembly of native non-covalent complexes of the catalytic domain with HA
domains. We will determine the structure of non-covalent gingipain surface complexes. Finally,
we will examine the pathogenic potential of different HA variants of Kgp expressed by P. gingivalis
strains. A conceptual innovation is characterizing the structures of full-length gingipains and native
RgpA-Kgp membrane complexes. This will shed new light on the cooperative mechanism of
proteolytic cleavage and adhesion/hemagglutination activity exerted by gingipains. Given their
specific bacterial surface localization, we posit that only simultaneous inhibition of both properties
will lead to the development of effective drugs against periodontitis and P. gingivalis-driven
systemic diseases.

Public health relevance
PROJECT NARRATIVE This research will fill a significant gap of knowledge on the maturation of Porphyromonas gingivalis-specific progingipains and their membrane surface assembly. This bacterium is important in microbial-induced gum disease and is linked to atherosclerosis, rheumatoid arthritis, some cancers, diabetes, and Alzheimer’s disease. Because the gingipains and their non-covalent surface complexes are essential for bacterial virulence, and there’s an urgent need to explore new therapeutic approaches as there is a lack of effective treatment for gum disease, a comprehensive mechanistic understanding of the maturation/assembly process is a prime target and therefore vital for therapeutic development which will positively impact human health.